Translation Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Translation Core (Core D)
The goal of the Translation Core is to encourage the application of findings from consortium research in practical
uses that improve the health and wellbeing of people living with AD/ADRD and their families and caregivers.
Written materials that report on consortium findings are an essential building block for all aspects of the Center's
translational infrastructure. We will build upon the NBER's existing research dissemination infrastructure, which
includes a health-focused newsletter, the NBER Bulletin on Health. We will also compile an annual literature
review that summarizes the most important scientific findings on the economics of ADRD prevention, treatment,
and care, published each year by consortium researchers and others. Research resources will be disseminated
through NBER's public use data archive at www.nber.org/data. The centerpiece of the translation core is an
annual conference that brings together researchers, policymakers, government officials, advocates, and other
stakeholders. The agenda for these conferences will consist of non-technical research presentations that
summarize findings from consortium research, soliciting of input from attendees and then extrapolating their real-
world implications for improving healthcare, caregiving, or other aspects of wellbeing for people living with ADRD
and their families. We will also convene one or more annual workshops in conjunction with national organization
conferences, such as the Alzheimer's Association International Conference, the Allied Social Sciences
Associations annual conference, or similar gatherings. In all these translation activities, we will feature findings
on the causes of health and healthcare disparities, and present actionable insights that promote health equity.